Leveraging epidemiological data to inform the development of a just-in-time adaptive intervention for diverse young adults co-using e-cigarettes and cannabis

PROJECT SUMMARY/ABSTRACT
Emerging evidence indicates that co-use of cannabis and e-cigarettes may perpetuate dependence on both
products and lead to adverse health outcomes in young people. Vulnerable groups, such as the Native
Hawaiian, Pacific Islander, and Filipino (NHPIF) young adults, often use these products at higher rates than
other racial/ethnic groups. However, substance use among NHPIFs has often been overlooked because of the
tendency among researchers to treat Asian American, Native Hawaiian and Pacific Islanders (AANHPIs) as a
monolithic group. Although AANHPIs are often regarded as a “low risk” group, when disaggregated, AANHPI
subgroups show marked health disparities, with NHPIFs indicating disproportionately higher rates of tobacco
and other substance use and higher burden of mortality due to cancer and cardiovascular diseases. Thus,
there is an urgent need to examine the unique risk factors that drive higher substance use among NHPIF and
rapidly translate findings into scalable interventions. Despite e-cigarette and cannabis co-use being common, it
has not been studied in NHPIFs. The current phased study will utilize epidemiological data from two sources
(R61 phase) – the cross-sectional Behavioral Risk Factor Surveillance System (BRFSS) and the longitudinal
Young Adult Health Behavior Survey (YAHB) – to guide the development of a Just-in-Time Adaptive
Intervention (JITAI) for e-cigarette and cannabis co-use (R33) among NHPIF young adults ages 18-30. JITAIs
allow for intervention components to be delivered in real-time through a smartphone application. In the R61
phase, we will identify the relative importance of various social determinants of health in predicting co-use
among NHPIF young adults. Across both surveys, we will examine associations between e-cigarette and/or
cannabis use, rates (prevalence and proportion of use), patterns, and progression (initiation, escalation, and
maintenance), with sociocultural (social vulnerability, family/peer influence and substance use), community,
and advertising/marketing factors, by ethnicity. We hypothesize that low-SES NHPIFs will be identified as the
most vulnerable group for co-use and that social influences will be most highly associated with use, initiation,
escalation, and maintenance. Findings will allow us to calibrate the proposed intervention and tailor the
balance of JITAI components in the R33 phase. Following initial development of the new JITAI, we will conduct
a pilot and qualitative interviews with 10 low-SES NHPIF young adults engaging in co-use to assess feasibility.
After additional intervention refinements, we will conduct an RCT (2-group) of the JITAI with low-SES NHPIF
young adults recruited from community sources who co-use e-cigs and cannabis assigned to intervention
(n=60) or ecological momentary assessment-only (n=60) to examine its impact on frequency and problem e-
cigarette and/or cannabis use.

Public health relevance
PROJECT NARRATIVE Emerging evidence indicates that vulnerable groups, such as Native Hawaiian, Pacific Islander, and Filipino (NHPIF) young adults, use e-cigarettes and cannabis at higher rates than other racial/ethnic groups, but past research has not examined co-use. The current phased study will utilize epidemiological data from two sources to guide the development of a Just-in-Time Adaptive Intervention (JITAI) for NHPIF young adults ages 18-30 who co-use e-cigarettes and cannabis. Following pilot work, a randomized controlled trial of the JITAI will examine the impact of the new intervention on frequency of e-cigarette, cannabis, and co-use and related problems.